The Impact of Traumatic Stress on the Methylome: implications for PTSD

Project Summary
It is not clear why some people develop posttraumatic stress disorder (PTSD) in response to a traumatic event.
DNA methylation, an epigenetic mark that associates with trauma and other environmental exposures,
associates with PTSD in multiple studies, and DNA methylation of some genes may be informative for early
prediction and treatment of PTSD. Over the last 3 years, the Epigenetics Workgroup of the Psychiatric
Genomics Consortium for PTSD (PGC-PTSD) has brought together data from 10 studies, with over 90
investigators from 10 countries to facilitate meta-analyses of DNA methylation (DNAm) data from cross-
sectional and longitudinal studies of PTSD in civilian and military cohorts. In this renewal proposal, we will
build on this highly productive collaboration by replicating our findings in an independent meta-analysis and
performing the largest epigenome-wide association study (EWAS) to date in >4,700 subjects, characterizing
PTSD-associated CpGs in postmortem brain tissue, identifying methylation quantitative trait loci (meQTLs) in
blood and brain relevant to PTSD, and characterizing DNAm changes over the course of PTSD treatment. We
are poised to rapidly and efficiently identify epigenetic markers informative for early prediction and treatment
and to provide context to genetic variants that predict risk and resilience following traumatic events. This study,
which aligns with ongoing PGC-PTSD efforts, will inform critical questions in the field related to the role of
blood-based methylation patterns as clinically-informative biomarkers and the degree to which they reflect
epigentic patterns in the brain; it will also provide insight into the biologic pathways underlying PTSD,
complement ongoing efforts to identify therapeutic targets, and inform prospective studies of PTSD and trauma
exposure that are underway.

Public health relevance
Narrative Multiple studies report DNA methylation differences that distinguish PTSD cases from symptom-free controls after exposure to a traumatic event. The purpose of this study is to identify replicable patterns of DNA methylation that associate with PTSD, characterize cross-tissue similarities between blood and brain, and determine the degree to which these patterns change in response to effective PTSD treatment.